University of Wisconsin Institute for Clinical and Translational Research

Contact PD/PI: Brasier, Allan
OVERALL ABSTRACT. This application is for renewal for the Clinical and Translational Science Award
(CTSA) at the University of Wisconsin-Madison (UW) Institute for Clinical and Translational Research (ICTR).
Through meaningful collaborations with partnering schools and our “spoke” organization, Marshfield Clinic
Research Institute, we expand support and innovation to accelerate clinical and translational research (CTR)
across our Hub. Over the past funding period, our KL2 scholars have successfully competed for $131M in
extramural funding. Our evidence-based CTR mentorship trained 501 master facilitators in 51 CTSAs. We
engaged regional networks in 90% of the counties in Wisconsin. Recently, ICTR led multiple impactful mid-
course corrections enabling our students, staff, and scientists to effectively address health inequities revealed
by the COVID-19 pandemic. Building on user needs assessments, SWOT analyses, and institute-wide
strategic planning we developed an Innovation Scorecard that serves as a roadmap to use continuous
improvement to address ongoing challenges in conducting efficient, rigorous, and engaged CTR. Our
application addresses 5 impactful Aims aligned with objectives in our Innovation Scorecard, each testing
explicit hypotheses. These Aims are: 1) Expand skills, efficacy, and resiliency of the CTR workforce to
engage effectively in multidisciplinary approaches to CTR. We test an eco-systems approach to promote
trainee resiliency, and propose to enhance academic recognition of clinical research, mentorship, and team
science. 2) Use bidirectional community engagement and inclusion training for increased involvement
of historically underrepresented groups in CTR leading to improved health equity. We will test whether
incorporating innovative stakeholder engagement, dissemination and implementation, and team science
approaches improve the fidelity and sustainability of interventions in health systems and communities. 3)
Employ intentional, systems-level change strategies to break barriers in diversity, equity, and inclusion
leading to a campus culture of “inclusive excellence.” We test evidence-based interventions on workforce
diversity and ability of translational reams to engage historically underrepresented groups in CTR. 4) Support
a sustainable informatics ecosystem to transform data to knowledge, enhance integration of research
into health care delivery, and promote rigor and reproducibility in CTR. We will provide and support
secure data sharing, interoperable systems, disease-focused registries and well-trained informaticians to
advance data-driven CTR. 5) Integrate a “concept-to-closure” support model for clinical research
engaging UW Health regional and national networks. We integrate support for CTR within UW Health. We
will test whether communities of practice for clinical trialists will enhance our CTR capacity. ICTR’s broad
reach, experienced leadership, high-functioning infrastructure, and partnerships will enable us to advance
translational science as a rigorous discipline, providing disruptive innovations in CTR.
Project Summary/Abstract Page 271
Contact PD/PI: Brasier, Allan
OVERALL

Public health relevance
PROJECT NARRATIVE This Clinical and Translational Sciences Award (CTSA) at University of Wisconsin-Madison (UW) supports innovation, training and development of evidence-based approaches to speed effective interventions into health and health care. We propose strategies to engage diverse trainees and underrepresented populations in the conduct, design and rigorous testing of interventions that are effective for all. Project Narrative Page 272